Investigation of FADA adhesin from Fusobacterium Nucleatum

Project Summary There have been no changes from the original submission.

Public health relevance
Project Summary There have been no changes from the original submission.